The role of the ribosome and translation factors in mediating stress signaling

A key feature of all living organisms is their ability to respond and adapt to an everchanging environment to
ensure cellular homeostasis. In response to chemical or physical stress, organisms activate a variety of
processes, including quality control mechanisms that preserve the integrity of biological molecules as well as
stress response pathways enabling them to mitigate the effect of damage. How and when cells switch between
these responses is highly regulated. For example, recent work from my group showed that in response to
chemical damage to mRNA, eukaryotes promptly activate ribosome quality control (RQC); on the other hand, if
the damage persists, they activate the integrated stress response (ISR). We have known for some time that the
ribosome and the translation machinery are key effectors for these pathways. Notably, however, we recently
showed that the ribosome itself is widely used as a sensor for these pathways. In particular, our work revealed
that collided ribosomes are the key signal for the activation of RQC and the ISR, and that they are in apparent
competition with each other, where the induction of one process suppresses that of the other. We note that much
of this work was motivated by our initial studies on the consequences of mRNA damage on protein synthesis.
However, it is clear that other species of RNA are also susceptible to damage, including ribosomal RNA.
Interestingly, the fate of chemically damaged ribosomes has received little to no attention, even though they are
known to accumulate in disease states and in response to certain chemotherapeutic treatments. As a result, we
will test the hypothesis that cells evolved nonfunctional ribosome decay to recognize and rapidly degrade
chemically damaged ribosomes. We are also interested in establishing the mechanism by which such defective
ribosomes are identified and distinguished from undamaged ones. Remarkably, emerging from our preliminary
studies is the observation that not only is RQC-mediated modification of collided ribosomes critical for the ISR,
but also for activation of the DNA damage response. Therefore, we will examine the hypothesis that the response
to RNA damage is a hitherto unappreciated pathway for cells to protect themselves expediently from damaging
agents. We propose that damaged mRNA and its induction of ribosome collisions serve as a molecular sentinel,
alerting cells to hazardous conditions that could damage either DNA or RNA. Finally, in exciting preliminary data,
we show that RNA polymerase II stability is intimately coupled to that of the translation factor eIF4E, which binds
the capped mRNA products of the polymerase. We propose that this mechanism evolved in eukaryotes as a
safeguard ensuring the flux of transcription is fine tuned to that of translation. We will test the model that RNAP
II is degraded through a quality-control step during proximal-promoter pause release, acting as a critical
checkpoint before elongation by the polymerase can proceed. Collectively, our proposed experiments will reveal
fundamental mechanistic insights into how organisms utilize the ribosome and the translational machinery to
respond to damaging agents through signaling pathways that also impact transcription and genome integrity.

Public health relevance
During their lifetime, organisms face a multitude of stress conditions that can be detrimental for maintaining cellular homeostasis. This has driven the evolution of distinct quality control and stress-response pathways that allow organisms to survive and adapt to the particular stress condition through regulation of gene expression; dysregulation of these pathways leads to disease states, including cancer and neurodegeneration. This proposal addresses how cells activate the appropriate response, which in turn could be invaluable in designing therapeutics aimed at dealing with defects in these pathways.